A New Phase in ABI1 Biology: AR We Abl to Characterize the Intractable AR-DNA-ABI1 Axis?

PROJECT SUMMARY/ABSTRACT
Intrinsically disordered proteins (IDPs) are a class of proteins that do not have a fixed three-dimensional
structure. IDPs can be fully unstructured, or contain modular regions of folded structure and unstructure, known
as intrinsically disordered regions (IDRs). IDPs/IDRs are dynamic; fluctuating through diverse conformational
ensembles that allow them to play widespread roles in biological functions, both during normal and pathological
conditions. IDPs/IDRs play a pivotal role in a multitude of cellular processes including, but not limited to,
proliferation, migration, differentiation, and apoptosis. Here, I will focus on Abl kinase Interactor 1 (ABI1), a
modular scaffolding protein, whose biophysical investigation had remain elusive for decades.
ABI1 is a multi-isoform and modular adaptor and scaffolding protein that plays a critical role in the
organization of the cytoskeleton via downstream coordination of actin cytoskeletal reorganization with growth
and proliferation signals as member of the WAVE complex. ABI1 also controls the progression of prostate tumors
and acts as a prostate tumor suppressor wherein loss of ABI1 contributes to tumor metastasis. It is now known
that ABI1 also functions in the nucleus, binding to DNA and nuclear hormone receptors (NHRs) like the androgen
receptor (AR). My overall goal is to investigate the molecular basis of ABI1’s nuclear functions. In Aim 1,
I will elucidate the mechanism of interaction between ABI1 and AR. Through biophysical methods, I will study
the interaction of full-length ABI1 and full-length AR. Through truncation analysis, I will also determine the
contribution of the folded domain(s) and IDR(s) from each protein towards binding and LLPS. In Aim 2, I will
determine how ABI1 binds DNA and I will determine how ABI’s interactions with AR reciprocally affects each
protein DNA binding properties. In this proposal, I will use an array of highly sensitive complementary biophysical
techniques to determine the DNA binding properties of ABI1 in the presence and absence of full-length and
various constructs of apo AR and AR bound to DNA. Due to their difficulty in expression and purification, there
is little in vitro data on the biophysical and structural mechanisms underlying the interaction between ABI1 and
AR.
The results obtained will elucidate how the DNA-ABI1-AR axis regulates transcription, and will set the
stage for developing novel inhibitors for prostate cancer. Without this knowledge, our understanding of ABI1’s
functions in regulating AR in normal and prostate cancer will remain limited. This work will have a positive impact
by providing a model for determining the mechanism of the interactions of ABI1 and other nuclear hormone
receptors, such as the estrogen receptor, a major driver of breast cancer.

Public health relevance
PROJECT NARRATIVE The androgen receptor (AR) plays a major role in transcriptional regulation and cell signaling in normal prostate cells, and is often dysregulated in most prostate cancers (PCa’s), thus AR is targeted for therapeutic treatment in PCa. Recent and emerging experimental data from the Bah-Kotula lab research collaboration has unveiled that Abl kinase-Interactor 1 (ABI1), a multi-isoform and scaffolding cytoskeletal adaptor protein, binds to AR and to chromatin in order to regular gene expression. However, the molecular underpinnings of this critical ternary interaction remain unknown; thus, I will elucidate the biophysical and structural basis governing the AR-ABI1- DNA axis, setting the stage for the development of novel therapeutics against PCa.